Postdoctoral Training in the Biology of Drug Abuse

Abstract:
The purpose of this training grant is to provide postdoctoral training to early-stage basic scientists and
physicians in the area of neurobiology of substance abuse at the genetic, molecular, circuit and behavioral
levels. Training will take place in the multidisciplinary setting at the University of Michigan. This is an exciting
and innovative environment with world class facilities and faculty needed to develop the next generation of
scientists working in drug abuse. The faculty members have expertise in the neurobiology of substance abuse,
with particular emphasis on opioid and psychostimulant drugs. The focus of the proposal is the scientific
training of postdoctoral fellows using state-of-the-art approaches for studying mechanisms underlying drug
abuse, and development of “soft skills” needed for long-term success (e.g., written and oral communication,
mentorship). Scientific training includes studying the genetic, developmental and environmental factors that
lead to vulnerability to substance abuse; the mode of action of drugs of abuse at the molecular, cellular,
anatomical and behavioral levels; the long-term consequences of psychoactive drugs on the brain, as
mediated through mechanisms of neural plasticity; and the development of medications, and prevention
strategies. The working assumption is that the functional and structural brain remodeling associated with
chronic drug use lies at the basis of tolerance, sensitization, physical dependence, and psychological addiction
to these drugs. The drug abuse research community at the University of Michigan is of high quality and has a
long history in the field. Beyond their individual strengths, the training faculty members have long-standing
collaborative scientific and training relationships with each other. These historical strengths are enhanced by a
number of initiatives at University of Michigan designed to facilitate life science research in general, and
neuroscience research in particular. They include state-of-the-art tools for mouse and rat genetics, genomics,
proteomics, and informatics and substantial programming and resources for postdoctoral career development.
Thus, our postdoctoral fellows will profit from a highly sophisticated, yet supportive, research and training
environment.

Public health relevance
Narrative This grant is designed to provide postdoctoral training to young basic scientists and physicians in the area of neurobiology of drug and substance abuse, with a focus on the mode of action of psychostimulant and opiate drugs at the genetic, molecular, circuit and behavioral levels. The objective is to provide an exciting and innovative environment with world class facilities and faculty to develop the next generation of scientists working in drug abuse. These scientists will have the skills to continue to study and work towards solving drug use disorders thereby supporting the mission of NIDA.